Breast Cancer Family Registry

ABSTRACT. The Breast Cancer Family Registry (BCFR) Cohort is a well-characterized international cohort of
multi-generational families that from its inception in 1995 has supported interdisciplinary collaborative research.
Across six sites in the U.S., Canada, and Australia, we recruited and continue to follow 33,037 women and 6,992
men from 15,056 families. Unlike cohorts of unrelated individuals, the BCFR Cohort enables a broad and deep
investigation of factors that modify breast cancer susceptibility and affect outcomes both before and after
diagnosis due to the unique characteristics of the cohort, including the full spectrum of familial and genetic risk
and the large proportion of women recruited under 45 years of age (n=12,384 (37%) at enrollment). The BCFR
Cohort is diverse with 26% of families from populations underrepresented in research (6% Asian/Pacific Islander,
6% Black, 8% Hispanic, 5% mixed ethnicity). We have created and maintained comprehensive biospecimen
resources (e.g., cell lines, DNA, plasma, tumor tissue). We have followed individuals who were unaffected
(n=27,753) or affected (n=12,276) with breast cancer at enrollment for up to 26 years (average length of follow-
up = 19.1 and 15.8 years, respectively), and we have prospectively ascertained 1,062 incident breast cancers
and 1,105 second breast cancer events (e.g., recurrences, second primary breast cancer) in the unaffected with
breast cancer and affected with breast cancer at baseline sub-cohorts, respectively. During the past four years,
we have expanded recruitment and enrolled 701 young women under age 45 years. In the next five years we
propose to further enrich the BCFR Cohort using a systematic and coordinated approach across all six BCFR
sites over the next five years by 1) expanding the Cohort through enrollment of 1,090 young women who are
newly diagnosed with breast cancer before age 45 years and at least one first degree relative, increasing the
racial, ethnic, and socioeconomic diversity (78% of young breast cancer families will be from underrepresented
populations); 2) enhancing the value of the full BCFR Cohort by following all participants through efficient data
linkages to environmental exposure and outcome databases (e.g., cancer and death registries); 3) maintaining
and expanding the biospecimen resources, including collection of plasma for cell-free DNA and urine; and 4)
continuing to promote and expand the use of BCFR resources by external investigators and large consortia
around the world. By including several novel components, we aim to answer questions on the role of life course
on accumulation of risk, critical windows of exposure, and the factors underlying the increase in breast cancer
incidence in young women. We will continue to serve as a resource to the international research community with
extensive epidemiologic and molecular data. We remain focused on addressing clinically important research
questions on breast cancer susceptibility, outcomes, survival and survivorship and remain committed to reducing
the breast cancer burden through discovery-based research about breast cancer development and progression.

Public health relevance
NARRATIVE: The Breast Cancer Family Registry (BCFR) Cohort is an international cohort in the U.S., Canada and Australia comprised of multi-generational families (33,037 women and 6,992 men from 15,056 families) that started in 1995. We will strengthen and continue to provide to the research community an important and unique long-term family cohort with extensive epidemiologic and molecular data to address cutting-edge and clinically important research questions on breast cancer susceptibility, outcomes, survival and survivorship with the overall goal of advancing knowledge of the biology of breast cancer development and progression so as to reduce the cancer burden and cancer disparities.